The classical complement system in post-traumatic thalamic neuroinflammation

PROJECT SUMMARY AND ABSTRACT
Traumatic brain injury (TBI) impacts 69 million individuals worldwide every year. Despite its prevalence, TBI
continues to be undertreated, so much so that the Centers for Disease Control and Prevention has dubbed it a
“silent epidemic”. TBI boasts no viable treatments, yet the long-term consequences can be profoundly disabling.
For example, up to 50% of TBI patients will develop chronic post-traumatic epilepsy (PTE), and a majority will
report sleep disturbances like sleep fragmentation and insomnia.
A leading candidate for the origin of these post-traumatic deficits is thalamic inflammation. Deep-brain
thalamic structures often show signs of robust gliosis and inflammation after TBI, even if the primary injury acutely
affects the cortex. The thalamus is a nexus for sleep, and its dense reciprocal connectivity with the cortex render
it highly epileptogenic. Studies in the Paz laboratory have shown that aberrant complement activation in the
thalamus, and in particular high levels of complement factor C1q, can lead to the development of post-traumatic
epileptic activity and a reduction in sleep spindles, electrophysiological signatures of non-REM sleep thought to
be crucial for memory consolidation. The question now remains how C1q exerts its maladaptive effects. The
proposed research will investigate the cellular source of maladaptive C1q through inducible genetic deletion,
EEG, and immunohistochemistry, and will determine the role that microglia—cells whose function in synaptic
pruning is known to be modulated by C1q—may play in mediating electrophysiological abnormalities due to C1q
(Aim 1). The proposed research will also explore the extent of the classical complement pathway’s participation
in the rise of epileptic events and sleep spindle loss by applying a highly novel nanobody against C4b, C1q’s
immediate downstream effector (Aim 2), coupled with many of the EEG and molecular techniques described in
Aim 1. These studies will be conducted with the ultimate goal of identifying avenues for potential therapeutic
treatment for TBI and its resultant deficits, including PTE and sleep disruption.
All research will be conducted at UCSF and at Gladstone Institutes and will benefit from the wealth of
resources and training available at both institutions. They will be enriched by in-house data science and statistics
tools and courses, and profit from internal and external collaborations. All experiments will be guided by the
mentorship of supervising sponsor Dr. Jeanne Paz, and made available for feedback and presentation at
conferences and meetings.

Public health relevance
PROJECT NARRATIVE Thalamic inflammation after traumatic brain injury is associated with a host of disabling and chronic deficits, including post-traumatic epilepsy and sleep disturbances, for which no approved treatments currently exist. This proposed work integrates molecular and electrophysiological techniques within neuroscience and immunology to probe how the overactivation of the classical complement system in the thalamus can set the stage for the development of long-term impairments. The ultimate goal of this research is to leverage and intercept immune pathology in the thalamus to guide the development of urgently-needed therapies for traumatic brain injury and its symptomology.